The 'Career MODE' Program: Careers through Mentoring and training in Omics and Data for Early-stage investigators

The National Academy of Sciences describes the barriers that scientists experience on the path from mentored to independent research as the single most critical threat to the future of biomedical sciences in the United States (US). Despite NIH’s separate grant reviews and paylines, the mean age at which investigators receive their first R01 has continued to climb to an all-time high of 46 years, extending a 35-year negative trend. In parallel, the likelihood of PhD graduates becoming professors has dropped significantly in the last decades, putting the future of biomedical research in the US at risk.
To address these challenges, we propose the 'Career MODE' program: Careers through Mentoring and training in Omics and Data for Early-stage investigators to empower the next generation of researchers across the US—i.e., postdocs in the final years of mentored training and faculty members within two years of their first appointment—to establish independent, successful careers in omics and data sciences. Omics— ranging from genomics to the microbiome—have revolutionized biomedical sciences. As they have become part of any biomedical field, the scarcity of a workforce within each discipline with appropriate omic training has emerged as a critical challenge. We seek to develop an 11-month program to provide intensive training in omics and data science and specialized mentoring from a nationwide network of 70+ experienced mentors. Career MODE will also feature training in professional skills, including leadership and team management, grant writing, mentoring, goal setting and strategy development, communication and teaching, scientific rigor, transparency, reproducibility, and responsible conduct of research. By leveraging its nationwide group of mentors and trainees, Career MODE will also offer a structured approach to enhance collaborations and networking, help create teams for breakthrough research projects and K99/R00 and R01-type grant proposals, further career development, and help secure tenure-track positions and faculty promotions.
Career MODE will feature hybrid (virtual and in-person) coursework and learning activities (boot camps, roundtables, panels, symposia, observerships), a robust evaluation of each objective, and will generate and disseminate extensive educational material on omics and data science. The program will do outreach to the most promising and motivated junior investigators—a group traditionally with limited training opportunities— to create empowered cohorts of scientists to pursue independence through advanced knowledge and tools in omics and data sciences applicable to all biomedical research fields. Thus, our program aligns with NIGMS goals and provides a high return on investment. We will also develop strategies to champion the need of integrated training in both omics and data sciences and promote Career MODE to academic institutions, sponsors, and stakeholders to reach financial sustainability and self-support beyond the five years of R25 funding.

Public health relevance
The development of omics technologies and the use of the most advanced data sciences has transformed every biomedical field and provides a limitless potential to understand biological processes and develop new treatments for human diseases. However, designing, executing, and analyzing data generated by these technologies requires significant specialized expertise, notably missing in junior investigators. The education program described in this proposal is designed to train a new generation of biomedical investigators and provide them with skills, knowledge, mentoring, professional skills, and networking to foster their pathways to independence using omics and data sciences.